Pooled shRNA screens for target discoveries in cancer

BACKGROUND. RNAi is a powerful tool for dissecting genetic interactions. We have developed technologies to conduct rapid and cost-effective shRNA library screens to identify genetic dependencies in cancer cells. PURPOSE. In this project we will collaborate with other investigators (primarily investigators in the NIH Intramural Program) to enable them to conduct shRNA screens in cancer cell lines. SIGNIFICANT MATERIALS AND METHODS. Pooled shRNA library targeting most annotated human genes. Individual shRNA clones for follow up hit validation and mechanism studies. FY2013 ACCOMPLISHMENT. We are currently engaged in a number of shRNA screens in difference cancer disease areas.